Recombinant botulinum toxin with improved safety and effectiveness for treatment of dystonia

Abstract
Botulinum neurotoxin (BoNT) is the most toxic protein known to science. It is also the active ingredient in
®
pharmaceutical products like Botox (Allergan), which have proven safe and effective for multiple neuromuscular
indications. All current BoNT products are manufactured from Clostridium botulinum cultures and have similar
safety characteristics, which include limitations on dosing and a black box warning in labeling. Because of its
inherent toxicity and narrow therapeutic window, optimal clinical outcomes are difficult to achieve in indications
involving large muscle groups, such as cervical dystonia, post-stroke spasticity and pediatric cerebral palsy.
Though improved muscle tone can clearly be achieved, clinicians tend to dose on the side of caution, and overall
clinical outcomes leave significant room for improvement. We here propose building on data generated with a
previous candidate for a “safer BoNT” pharmaceutical (SBIR Phase 1 1R41NS086115-01A1) which found that
specific amino acid substitutions to BoNT/A1 can produce a recombinant BoNT/A1 with an improved safety
margin compared to wt BoNT/A1, (US 8,865,186). The initial lead candidate designed and tested, Cyto-012, had
an improved safety margin, but its absolute potency was such that doses required for efficacy were also
immunogenic. Here, we propose testing a new recombinant BoNT/A1 derivative termed Cyto-014, designed to
have potency and immunogenicity similar to wt BoNT/A1, while retaining the desired improvement in safety
suggested by our Preliminary Studies. This proposal is intended to compare the dose-response behavior, safety
margin and maximum tolerated dose of Cyto-014 relative to wt BoNT/A1 in appropriately powered studies, and
to evaluate its immunogenicity and effectiveness for repeat treatment. Successful completion of the proposed
studies will support a Phase II study to focus on pre-clinical development activities aimed at filing an IND.

Public health relevance
Project Narrative Botulinum neurotoxin (BoNT) has become an important therapeutic tool for the treatment of neurological diseases associated with dystonia and spasticity disorders, despite the fact that BoNT is the most poisonous protein known to science. This proposal will develop a de novo recombinant BoNT (rBoNT) drug with an improved safety margin relative to the current BoNT/A1 products, which are all currently derived from Clostridia. The planned work is based on an established technology platform for engineering rBoNT derivatives to address specific clinical needs. A lead candidate, Cyto-014, has been designed, expressed, purified and tested. Preliminary data suggest that Cyto-014 has the desired safety and effectiveness characteristics. This proposal will compare the potency and safety margin of Cyto-014 to wt BoNT/A1nusing appropriately powered studies, and evaluate whether Cyto-014 exhibits any undesirable immunogenic or inflammatory activity.